Botanical Core

PROJECT SUMMARY_BOTANICAL CORE
Many botanicals are touted to have beneficial effects on cognition, mood, sleep quality and other functions that
are diminished during aging. An abiding challenge with scientific studies involving botanicals is the complexity
and variability of their chemical profile as well as ambiguities in the identity and species homogeneity of
botanical preparations. The proposed Botanical Dietary Supplement Research Center (BDSRC) will perform
studies critical to future clinical trials of “Botanicals enhancing neurological and functional resilience in aging”.
Based on